Opioid actions on the habenulo-peduncular circuit

PROJECT SUMMARY
Withdrawal is a major obstacle in overcoming opioid dependence and addiction. Identifying the neural circuits
involved and how opioids modulate the activity of those circuits is essential for developing new therapeutic
approaches to prevent or treat opioid use disorder. The medial habenula (MHb) projects primarily to the
interpeduncular nucleus (IPN) and has long been known to express high levels of the Mu-opioid receptor (MOR).
Activity in this circuit has been associated with expression of fear and anxiety; and repeatedly implicated in
mediating aversive qualities of nicotine and nicotine dependence. Emerging evidence also supports a role for
MHb projections to IPN in the somatic and affective symptoms of opioid withdrawal. Despite this, there is
remarkably little information on what cell types in both MHb and IPN express MOR, how MOR signaling
influences this circuit, and whether chronic MOR signaling induces physiological changes in this circuit that
contribute to withdrawal. In this proposal we propose experiments to inform each of these questions using a
combination of molecular, physiological, and behavioral approaches to investigate MOR-expressing neurons in
both MHb and IPN of mice. Based on prior literature and preliminary data we posit an important role for excitatory
neurons in lateral MHb and inhibitory neurons in rostral IPN in mediating aversive qualities of opioid dependence
that contribute to withdrawal and relapse.

Public health relevance
PROJECT NARRATIVE Opioid abuse is a massive public health crisis; maintenance therapies can help wean people off opioids but additional therapeutic approaches are much needed. Here we propose to evaluate the effects of opioids on an overlooked neural circuit that plays a known role in nicotine dependence but that also expresses high levels of the receptor that opioids act on. This work will provide new information on how opioids induce dependence and new avenues for preventing or treating opioid use disorder.